Biology and Engineering of Botulinum Neurotoxins.

Botulinum neurotoxins are a family of seven bacterial toxins (BoNT/A-­G). Members of the BoNT
family have been widely utilized for treating a growing list of medical conditions. During our
previous funding cycle, we carried out the first comprehensive investigation of the effect of
BoNTs on survival of neurons. We identified two of the toxins, BoNT/C and BoNT/E, that induce
death of neurons. We further established that neuronal death is due to blockage of a plasma
membrane recycling process by BoNT/C and E. These findings open a new line of inquiry on
toxin biology and reveal a novel membrane recycling process essential for neuron survival.
Following these findings, we further found that amyloid precursor protein (APP) is a major cargo
of the membrane recycling process blocked by BoNTs. Here we propose mechanistic studies to
elucidate this essential membrane recycling process at the molecular level. We will also utilize
BoNTs as a novel tool to address key questions about APP recycling/processing and explore
the potential role of APP in BoNT action at nerve terminals. Finally, our current studies
established that SNAP-­25, which is cleaved by BoNT/A, C, and E, is essential for neuron
survival and APP recycling. This finding raised a significant safety concern regarding long-­term
use of the major therapeutic toxin BoNT/A, which prompted us to develop alternative therapeutic
toxins through protein engineering.
Our proposed studies will provide a mechanistic understanding of the effect of BoNTs on
survival of neurons and may yield novel insights into APP biology. They will also address
concerns about the long-­term safety of current therapeutic toxins and aim to develop a new
generation of therapeutic toxins with improved efficacy and safety in humans.

Public health relevance
Botulinum neurotoxins (BoNTs) are widely used to treat a growing list of medical conditions. Members of the BoNT family cause the death of neurons by blocking a plasma membrane recycling pathway. Here we seek to gain a mechanistic understanding of this critical pathway (which also contains the amyloid precursor protein involved in Alzheimer disease) and we also aim to develop a new generation of therapeutic toxins with improved efficacy in humans.